CoVPN Vaccine Site Preparation

Project Summary/Abstract Given the rapid spread of SARS-CoV-2 infection, the on-going global pandemic, and the risk for seasonal recurrence there is a critical need to test emerging vaccine candidates in phase 3 efficacy trials. Due to its experience in implementation of global HIVAIDS prevention efficacy trials and its operational capacity to respond to a new global pandemic, the HPTN, in collaboration with the HVTN, is providing operational support for the newly constituted COVID-19 Prevention Network (CoVPN). Preparing for a series of large scale efficacy trials, this application outlines aims required to build the infrastructure capacity to rapidly implement them over the coming month. The requested funds are to prepare clinical trial sites for implementation of these trials. The HPTN will support 30 clinical trials sites in the United States, South America, and Sub-Saharan Africa so they can begin enrollment in NIH supported COVID-19 vaccine and monoclonal trials planned for implementation over the next 6 months.

Public health relevance
Project Narrative The outbreak of SARS-CoV-2 across the globe presents an unprecedented health and economic challenge to the worlds’ population, one that may not be ameliorated until an effective vaccine is developed. The CoVPN is dedicated to this task and will work together with the pharmaceutical industry to test viable candidate vaccines and monoclonal antibodies in several efficacy trials. The proposed administrative supplement will provide support to HPTN-assigned clinical research sites to expand the operational and clinical site capacity necessary to implement these trials in both the US and in international sites. These capacity measures will contribute to the public health response in preventing further spread of the disease and is in accordance with the HPTN ethical obligation of protection of human subjects in clinical research.